PANDAA for universal, pan-lineage molecular detection of Crimean-Congo Hemorrhagic Fever virus.

Crimean-Congo hemorrhagic fever virus (CCHFV) is a global health threat due to the widespread and expanding
geographical distribution of the tick vector, the absence of specific medical interventions for treatment and
prevention, and its rapid-onset hemorrhagic fever with a 10-50% case-fatality rate. It is the most geographically
widespread tickborne virus and the causative agent of Crimean-Congo hemorrhagic fever (CCHF), one of the most
severe zoonotic viral diseases in humans. Undifferentiated febrile illness is among the most common reasons for
people seeking medical care in resource-limited countries, and CCHF is difficult to diagnose in its early pre-
hemorrhagic stages due to non-specific symptoms that can be associated with various febrile illnesses. To address
this, we developed PANDAA CCHFV—the first universal, pan-lineage CCHFV diagnostic to meet the WHO R&D
blueprint target product profile—during our SBIR Phase II. Aldatu’s pioneering PANDAA technology enables probe-
based qPCR for target detection in highly variable genomic regions by simultaneously adapting and amplifying
diverse viral variants. PANDAA uniquely mitigates the presence of genetic polymorphisms in viral variants to allow
the detection of otherwise divergent targets by fluorescent probes. As such, we are distinctly positioned to
commercialize the first rapid, sensitive molecular CCHFV diagnostic assay with pan-lineage coverage and superior
performance compared to existing diagnostics that won’t be affected by genetic changes in new viral variants.
Through these Phase IIB milestones, we will establish regulatory and quality frameworks for manufacturing and
commercializing PANDAA CCHFV as a rapid and sensitive molecular assay with superior performance to existing
diagnostics. We will expand our existing quality management system (QMS), which is compliant with international
standards for medical device manufacturing, to incorporate in-house cGMP manufacturing of PANDAA CCHFV. With
our evaluation partners, we will perform pre-commercialization studies in multiple high-priority markets to determine
performance using clinical samples from all CCHFV clades. This will generate the necessary data to submit PANDAA
CCHFV for CE certification as an in vitro diagnostic (IVD). This will be accompanied by implementing our initial go-
to-market strategy in 3-5 short list countries. We will have identified and vetted clinical study partners, distributors,
and other regional partners to support Aldatu in negotiations and contracting with local partners and facilitating
engagement with Ministries of Health. We will precede our go-to-market launch with early site evaluations by
collaborators in key target markets where they will perform concordance studies with existing CCHFV assays. The
net result will be the manufacturing and regulatory qualification of PANDAA CCHFV, which will provide a rapid,
standardized testing option—deployable using pre-existing qPCR equipment in central labs in CCHFV-endemic
regions—to radically reduce CCHFV diagnostic test complexity, time burden and costs without sacrificing accuracy.

Public health relevance
Crimean-Congo hemorrhagic fever virus (CCHFV)—listed among the urgently concerning pathogens prioritized in the WHO R&D Blueprint List of Priority Diseases— causes severe hemorrhagic fever in humans that is difficult to clinically diagnose as the early (i.e., pre-hemorrhagic) stages present with non-specific symptoms associated with a range of febrile illnesses that are also displayed by other infectious agents endemic to affected areas e.g., malaria, yellow fever, dengue fever, influenza, or Lassa fever. This Phase IIB SBIR submission will commercialize the results of our successful Phase II SBIR where we leveraged the unique capabilities of our qPCR-enabling technology, PANDAA, to successfully market the first rapid, sensitive molecular diagnostic CCHFV assay with pan-lineage coverage and superior performance compared to existing diagnostics that won’t be affected by genetic changes in new viral variants. We will establish the regulatory and quality frameworks necessary to manufacture the associated product, PANDAA-CCHFV, that will provide a rapid, standardized testing option for all CCHF-endemic regions and can be deployed using pre-existing qPCR equipment in central labs to radically improve the CCHFV diagnostic workflow by reducing test complexity, time burden and costs without sacrificing accuracy.